Targeting SMARCA2 as a therapeutic strategy in SMARCA4 mutant lung cancer

Project Summary
Lung cancer is the top cause of cancer mortality. Despite recent advances, the majority of patients with
lung cancer lack effective therapeutic options, underscoring the dire need for additional treatment approaches.
Genomic studies have identified frequent mutations in subunits of the SWI/SNF chromatin remodeling complex
including SMARCA4 and ARID1A in non-small cell lung cancer with a frequency of up to 33% in advanced stage
disease, making it the most frequently mutated complex in lung cancer. Recent reports and our own data have
identified the paralogue SMARCA2 to be synthetic lethal to SMARCA4. However, identifying selective inhibitors
of SMARCA2 has been challenging. Hence, we have developed novel SMARCA2 degrading small molecules
based on the proteolysis targeting chimera (PROTAC) technology. We demonstrated that YD23, our lead
SMARCA2 PROTAC, potently and selectively induces degradation of SMARCA2. We further showed that YD23
selectively inhibits growth of SMARCA4 mutant lung cancer cells. Mechanistically, we showed that YD23 induces
changes in chromatin accessibility only in SMARCA4 deficient cells.
Taking these observations together, we hypothesize that SMARCA2 degradation using YD23 is an
attractive therapeutic strategy with promising therapeutic index in lung cancers with inactivating mutations in
SMARCA4. The major objective of the proposed study is to provide preclinical evidence to guide future
development of YD23 (or its analogs) in patients with SMARCA4 mutant lung cancer. While we have shown
marked sensitivity of SMARCA4 mutant lung cancer cell lines to YD23, we still do not know the detailed
mechanistic basis for this activity. Hence, we intend to perform gene expression, epigenetic and chromatin
accessibility studies followed by integrative analysis to triangulate on direct target genes whose chromatin
landscape is altered by presence or absence of SMARCA2 in SMARCA4 mutant cancer cells. While our in vitro
cancer cell growth inhibitory studies are encouraging, a systematic exploration in vivo using various orthogonal
model systems is required to aid the preclinical development of SMARCA2 degraders. Thus, we propose to
determine the potential of YD23 mediated SMARCA2 degradation in SMARCA4 mutant xenograft and patient
derived xenograft (PDX) model systems. Due to the unique microenvironment of lung cancer we will also test
efficacy of YD23 in GEM models of lung cancer. Finally, SMARCA2 as a synthetic lethal partner of SMARCA4
has so far been described by in vitro experiments. In vivo genetic validation is critical to unequivocally
demonstrate the requirement of a gene of interest in the development of a genetically defined subtype of cancer.
Thus, we aim to perform CRISPR-Cas9 mediated Smarca2 genetic ablation to determine the extent of its
involvement in the development and biology of Smarca4 mutant GEM models. In conclusion, our study is
expected to provide mechanistic insight into the synthetic lethal genetic relationship between SMARCA2 and
SMARCA4 and lay the foundation for future clinical development of SMARCA2 degraders as therapeutics.

Public health relevance
Project narrative Despite promising new therapeutics, lung cancer remains a devastating disease and is the top cause of cancer mortality. We and others recently showed that a a protein named SMARCA2 is essential for growth of a subtype of lung cancer and discovered a potent chemical molecule that degrades this protein. In this proposal, we aim to perform in depth biological studies to better understand the mechanism of the growth inhibitory activity of SMARCA2 degradation using chemical biology and genetic approaches as well as explore the therapeutic potential of SMARCA2 degradation by our molecule in such tumors.